Context-dependent turning of muscle spindles

Project Summary
Muscle spindles provide sensory information critical for our balance and movement, yet their firing during active
conditions remains poorly understood. This lack of understanding of muscle spindle function in voluntary conditions
creates both scientific and clinical barriers to understanding the role of muscle spindles in healthy and impaired control of
balance and movement. While the efferent drives to the gamma motor neurons (gamma drive) that innervate the muscle
spindle are known to modulate the sensory signals from the muscle spindle according to the internal state (including
attention, emotion, and task-goal), much of the studies are done using passive imposed movements. We propose a novel
approach combining a computational biophysical model of muscle spindles with direct recordings from human leg muscle
spindles using microneurography and muscle fascicles using ultrasound during voluntary isolated-joint and standing
balance tasks. PI Ting and Co-I Simha have recently developed a computational model of muscle spindle that simulates
the intrafusal crossbridge dynamics, allowing it to be generalized to a variety of movement conditions. The model predicts
that the muscle spindle firing follows muscle fascicle length changes during passively imposed movements, including an
initial burst at the beginning of the first stretch. Collaborator Bent is one of the handful of people in the world who can
obtain microneurography measurements from human lower limbs and has recently published on the relationship between
muscle fascicle length and muscle spindle firing in the human leg muscles in response to imposed sinusoidal movements
during seated rest conditions. In Aim 1, we propose to measure muscle spindle firing in response to similar sinusoidal
movements performed voluntarily and to use our model to understand the observed muscle spindle firing in the context of
differing gamma drives. In Aim 2, we will extend our model to understand muscle spindle firing during natural and
robotically-assisted postural sway. We will use the expertise of Collaborator Blouin, who has designed a unique robotic
device that can decouple body part movements during human standing balance to identify sensorimotor control
mechanisms. This unique combination of recent developments in computational modelling and robotic technology with
the delicate and increasingly rare microneurography method allows us to understand muscle spindle function in the lower
limbs during voluntary behavior in humans. The only data from human muscle spindles during voluntary movement are
from many decades ago when technological limitations prevented measurements of muscle fascicle kinematics,
application of decoupled body part movements during standing balance, and using computational models to infer the role
of gamma drive, all combined in one experiment. The results from this proposal will significantly advance our basic
understanding of human sensorimotor control of balance and movement, as well as provide a mechanistic framework for
understanding neuromotor impairments such as spasticity that may arise from the dysregulation of gamma drive in
chronic motor impairments in conditions such as cerebral palsy, stroke or spinal cord injury.

Public health relevance
Project Narrative Sensory information from our muscles is critical for balance, gait, and other movements and is dysregulated in cerebral palsy, stroke, and spinal cord injury, causing debilitating motor symptoms such as spasticity. However, we currently do not understand how one of our primary sensory organs, the muscle spindle, functions during behavior. In this proposal, we aim to combine recent advances in computational modelling and robotic device development to understand muscle spindle function in human leg movement and balance.